SAFETY AND TOLERANCE OF A SINGLE ADMINSTRATION OF AZALINE B IN FEMALES

To assess the safety, tolerability, pharmacokinetics and pharmacodynamics of azaline B when administered as a single subcutaneous injection in healthy female volunteers who have experience surgical or natural menopause.